Liver Diseases and Pregnancy Complications

As an organ responsible for nutritional and energy metabolism, liver plays important roles in maintaining normal
pregnancy. Liver diseases during pregnancy is relatively poorly studied and represents one of the gaps for liver
research. Approximately 3-5% of pregnant women are affected by liver diseases during pregnancy. When
severe, those liver diseases are associated with significant morbidity and mortality for both mother and infant.
Intrahepatic cholestasis of pregnancy (ICP) is the most common liver disease unique to pregnancy while non-
alcoholic fatty liver disease (NAFLD) is the most prevalent primary liver disease occurring during pregnancy.
Recent clinical and our preliminary studies have revealed that women with ICP and NAFLD have an increased
risk for developing pregnancy complications of preterm birth (PTB) and stillbirth. However, the etiological link
and underlying mechanisms remain to be determined. Currently there are limited intervention options to prevent
or reduce pregnancy complications of PTB and stillbirth for pregnant women with liver diseases. In our recent
and preliminary study with 36,755 pregnant women, we found that serum total bile acid (sTBA) levels directly
correlate with the pregnancy complications of PTB and stillbirth and both ICP and NAFLD patients had markedly
elevated sTBA levels. Bile acid cholic acid (CA) dose-dependently induced pregnancy complications of PTB and
stillbirth and restoring bile acid homeostasis markedly reduced PTB and dramatically improved newborn survival
rates. So, it was concluded that elevated bile acids are the etiological linker between liver diseases ICP and
NAFLD and pregnancy complications of PTB and stillbirth. The overall objective of this proposal is to
understand the mechanistic linkages among ICP, NAFLD, bile acids and pregnancy complications as well as the
underlying mechanisms. The central hypothesis, built on our extensive preliminary results, is that elevated bile
acids in pregnant women with liver disorders such as ICP and NAFLD induce pregnancy complications of PTB
and stillbirth through activating the Takeda G protein-coupled receptor 5 (TGR5) signaling pathway, and restoring
bile acid homeostasis by drugs will reduce or prevent bile acids-mediated pregnancy complications of PTB and
stillbirth. Three specific aims will be conducted. Specific Aim 1 is to investigate the roles of TGR5 signaling
pathway in the induction of pregnancy complications by elevated bile acids. Specific Aim 2 is to investigate
increased risk and underlying mechanisms for NAFLD subjects to develop ICP and its associated pregnancy
complications. Specific Aim 3 is to investigate the therapeutic potentials of four types of FDA-approved
drugs that modulate bile acid homeostasis on pregnancy complications. The experiments proposed are
built on our extensive, robust and novel preliminary findings, animal models established as well as our long-
standing experience in studying bile acid regulation and associated liver diseases. our team is thus uniquely
poised to investigate the underlying mechanisms and develop potential therapies for liver diseases-associated
and bile acids-induced pregnancy complications of PTB and stillbirth.

Public health relevance
Liver plays important roles in maintaining normal pregnancy. Pregnant women with liver diseases have increased risk for developing pregnant complications including preterm birth and stillbirth. However, our current understanding on the underlying mechanisms and treatment option are limited. This proposal is aiming at filling in those gaps to investigate the underlying mechanisms of increased pregnancy complications in pregnant women with liver diseases and develop novel mechanism-based interventions to reduce or prevent pregnancy complications in those affected populations.